Overcoming Therapy Resistance in SCLC

PROJECT SUMMARY/ABSTRACT
Small cell lungcancer (SCLC) is a pulmonary neuroendocrine cancer with very poor prognosis and limited
effective therapeutic options. Chemotherapy has been used for the past 30 years as for the treatment for SCLC.
While most SCLCs initially respond to this treatment, nearly all relapse. Recently, immunotherapies have been
introduced in SCLC treatment. While these treatments have revolutionized the treatment of non-small cell lung
cancer (NSCLC), they are only effective in a very small subset of SCLCs. Thoracic radiation is recommended in
the course of both limited stage (LS) and extensive stage (ES) SCLC. Radiation has been shown to induce
durable responses by engaging anti-tumor immunity. However, radiation therapy while effective in some
individuals, does not always convert immunologically non-responsive “cold” tumors to become immune
responsive “hot”. These observations highlight the need to develop new effective treatments for SCLC.
In many cancers, the loss of cell cycle checkpoints, together with oncogene activation, leads to cell survival even
with high levels of replication stress (RS) and DNA damage. Cellular pathways respond to RS, to ensure that
DNA is properly replicated and to prevent cells from prematurely entering mitosis. However, in most advanced
solid tumors, there is an increase in a variety of errors during DNA synthesis, disruption of the DNA damage
response, and mitotic catastrophe. This continuous and high degree of RS and dependence on DNA repair
provides a potential cancer vulnerability and therapeutic opportunity. The vast majority of human tumors
including nearly all of SCLCs are dependent on telomerase holoenzyme to bypass replicative senescence
resulting from telomere shortening with each cell division and this creates a dependency. We are proposing to
utilize a molecule that interferes with the function of telomerase to rapidly stop SCLC growth with minimal or no
cytotoxic side effects in normal telomerase silent tissues. In our preliminary studies, we discovered that this
molecule not only can kill cancer cells in culture dish, it can also activate the immune system when given
intermittently to the mice. We propose to discover how this molecule sensitizes SCLCs to radiation or
chemotherapy treatment (Aim 1), Induce immune responses (Aim 2), and to determine whether it can overcome
resistance to existing treatments (Aim 3). For this goal, we will utilize fully immunocompetent mouse models.
Therapies that activate immune system have been less toxic compared to other treatments and often provide
more durable responses in patients. We hope that our studies with this molecule will generate information to
develop rationally designed clinical trials which utilize combinations with minimal toxicity and maximum
therapeutic efficacy in small cell lung cancer

Public health relevance
PROJECT NARRATIVE Unlike normal cells, majority of cancer cells and nearly all of small cell lung cancers activate an enzyme called telomerase to replicate end of the chromosomes to bypass replicative senescence. Telomerase is essential for the survival of these cancer cells. We are proposing that targeting telomerase can sensitize small cell lung cancer to existing therapies.